A high-throughput assay to measure amyloid-β oligomer formation

Project Summary
Toxic oligomers formed by amyloid-beta (Aβ) self-association are of high interest for research
into the causes and treatment of Alzheimer's Disease. Studies Aβ oligomer formation on a
molecular level using biophysical and analytical techniques have provided many valuable
insights, but there remain many open questions regarding oligomer structure and the factors
that influence their formation. In the present proposal, we will develop a new method for
studying Aβ oligomerization that greatly diverges from the biochemical and biophysical
approaches historically utilized by the field. Here, we will use a genetically encoded sensor that
detects Aβ oligomer formation and converts the oligomer formation event to the expression of a
reporter gene, enabling high-throughput and direct measurements of Aβ oligomerization. This
format enables us to measure the effects of millions of different factors on Aβ oligomerization
and to quickly identify agents that can selectively bind oligomers over other Aβ species.
1

Public health relevance
Project Narrative This work seeks to develop a new model to study amyloid-β oligomers, which hypothesized to be one of the toxic species leading to neurodegeneration in Alzheimer's Disease. Using this model, we seek to uncover the molecular factors that influence oligomer formation and to identify agents that can bind to and detect oligomers with high affinity and selectivity over other amyloid-β species. 1